Development of high-throughput CETSA target engagement assays

Demonstrating binding of a small molecule to a target within a cellular environment is valuable for confirming on-target activity. During this period, the collaborative team has developed a split-reporter complementation CETSA (SplitLuc CETSA) that can be used to perform CETSA In 384 and 1536-well plates. The team is continuing to develop the technology to further streamline workflow and improve data acquisition, to allow for rapid testing of CETSA for lead optimization and high-throughput screening.